Transforming Mammography With STARLIGHT, Imagine Scientific's Monochromatic X-Ray Imaging System

Transforming Mammography With STARLIGHT
Imagine Scientific's Monochromatic X-Ray Imaging System
ABSTRACT
Imagine Scientific has invented the first and only practical, IP-protected, cost effective, high power
monochromatic X-ray source with short exposure times for diagnostic imaging in the clinic. This long-awaited
breakthrough for radiology is called STARLIGHT, which provides an extensive range of selectable
monochromatic energies with sufficient intensity and beam coverage for many radiological imaging procedures.
Its initial application for commercial development is as an X-ray source for mammography. STARLIGHT offers
(i) superior detection of tumors for all women, including those with thick and dense breasts, (ii) significantly lower
radiation dose, and (iii) elimination of painful breast compression during examinations.
Invasive breast cancer, the most common cancer in women, affects 1 in 8 US women. Over 260,000 new
cases are diagnosed annually and over 40,000 women die each year, mostly those diagnosed with advanced
stage cancer. Though mammography detects cancer in ~ 85% for women with low breast density (BI-RAD
categories 1 and 2), screening is much less effective (48%-64%) for the 40%-50% of women who have dense
breasts (BI-RAD categories 3 and 4), increasing their risk of developing cancer as much as 4 to 6 times.
STARLIGHT addresses unmet women’s healthcare needs caused by the performance limitations of
current mammography systems. A mammography machine using monochromatic X-rays will have higher
sensitivity and specificity than conventional mammography, yielding better detection of cancers while
considerably lowering false-positive findings, potentially preventing the costs and high stress of unnecessary
biopsies,and referrals for adjuvant ultrasound and MRI scans. In addition to a more conclusive diagnosis, women
screened with STARLIGHT-based mammography systems will receive considerably lower radiation dose and
findings based on industry-standard phantom measurements in the Imagine Scientific laboratory suggest the
STARLIGHT system also reduces the painful breast compression experienced with conventional mammography.
Monochromatic mammography’s superior performance has the huge potential to improve detection sensitivity at
a lower radiation dose for early-stage cancers in the ~45 million women screened each year (US) and
substantially reduce morbidity associated with misdiagnosed or late-diagnosed breast cancer.
STARLIGHT is the first, high power monochromatic X-ray source for diagnostic imaging in the clinic. It
delivers sufficient monochromatic X-ray emission in a pulse, enabling the short exposure times required for 2-D
full-field mammography (FFDM) and 3-D digital breast tomosynthesis (DBT). STARLIGHT can be integrated into
conventional 2-D and 3-D mammography systems, which means no physical modifications are needed in breast
imaging centers. Furthermore, using monochromatic X-rays does not require changes in clinical workflow and
operating procedures. The cost to manufacture a STARLIGHT X-ray source is similar to current conventional x-
ray sources used for mammography.
In Year 1, Imagine Scientific will complete the fabrication of two commercial-grade versions of
STARLIGHT for installation in commercial mammography systems. Together with collaborators from the
Massachusetts General Hospital (MGH) and the University of California at San Diego (UCSD), the team will use
one instrument to show superior image quality and lower radiation doses compared to current mammography
systems in a series of 2-D and 3-D tests with industry phantoms. In Year 2, it will use the second unit in a
dedicated clinical trial at Duke University Medical Center to demonstrate specific and important clinical benefits
of monochromatic imaging. We will continue to develop a collaborative manufacturing and marketing plan with
Varex Imaging Corporation while concurrently refining and testing STARLIGHT at Imagine Scientific.

Public health relevance
Transforming Mammography With STARLIGHT Imagine Scientific's Monochromatic X-Ray Imaging System Project Narrative Imagine Scientific has invented the first and only practical, IP-protected, cost effective, high power, monochromatic X-ray source with short exposure times for diagnostic imaging in the clinic. This long-awaited breakthrough for radiology is called STARLIGHT, which provides an extensive range of selectable monochromatic energies with sufficient intensity and beam coverage for many radiological imaging procedures. Its initial application for commercial development is as an X-ray source for mammography. STARLIGHT offers (i) superior detection of tumors for all women, including those with thick and dense breasts, (ii) significantly lower radiation dose, and (iii) elimination of painful breast compression during examinations. In Year 1, we intend to finish the commercial development and fabrication of the advanced STARLIGHT source, and together with collaborators from the Massachusetts General Hospital (MGH) and the University of California at San Diego (UCSD) in Year 2, conduct a clinical trial at Duke University Medical Center to demonstrate specific and important clinical benefits of monochromatic imaging.